Dissecting neural circuits underlying early life stress-induced PFC dysfunction

Project Summary
Autism Spectrum Disorders (ASDs) comprise a group of severe neurodevelopmental disorders that are typified
by communication deficits and social impairment. Given that the onset of symptoms occurs by the age of 3, it is
largely agreed that neuronal dysfunction arises during early brain development. A developing brain shows a
remarkable capacity for plastic changes in response to experiences; thus, its development is most vulnerable to
the environmental factors that can derail normal brain function. Exposure to early life stress in the form of
abuse/neglect during a critical period of brain development has demonstrated behavioral and psychological
deficits that closely resemble autistic symptoms in both animal models and human studies. Thus, it is essential
to identify the neural mechanisms underlying early life stress-induced social dysfunction for the development of
treatment strategies for complex behavioral deficits in children with ASD. Recent studies have shown that early
life stress in rodents induces long-lasting brain alterations similar to the deficits seen in patients with ASDs,
including dysfunctions in the prefrontal cortex (PFC) and the stress/reward-related circuitry originating in the
ventral tegmental area (VTA). Formation of excitatory synapses in the PFC is known to be essential for the initial
establishment of functional neural circuits. Conversely, disrupted synapse development impairs PFC function
and is thought to underlie the pathology of multiple neurodevelopmental disorders. The PFC is densely
innervated by dopaminergic axon terminals and associated with higher cognitive processes that may be
disrupted in illnesses such as ASDs. In this R21 proposal, we utilize a novel combination of methods including
early social deprivation stress paradigm and two-photon imaging and uncaging to test our hypothesis that early
life stress-induced dysregulation of PFC-projecting dopamine neurons constitutes a neural mechanism by which
adverse events early in life alter PFC function and may cause behavioral dysfunction in adulthood. Guided by
strong preliminary data, we will examine this hypothesis in two specific aims: 1) Define functional changes in
PFC-projecting VTA dopamine neurons following early life stress. 2) Determine mechanisms of dopamine-
induced synapse development in the PFC following early life stress. Results from these studies will further our
understanding of the unique and detailed mechanisms by which dopamine regulates brain development, with
critical relevance to cellular underpinnings of neurodevelopmental disorders. Approximately 1 per 100 children
in the U.S. is a victim of abuse and neglect. We expect that our results will highlight new avenues into the
investigation of the pathophysiology underlying neurodevelopmental disorders resulting from early perturbation
of dopamine signaling.

Public health relevance
Narrative Exposure to early adverse experiences is associated with an increased risk of developing social dysfunction that resembles autistic symptoms. The prefrontal cortex (PFC), a major cortical recipient of dopaminergic inputs, plays important roles in emotional functions as well as in social behavior. Defining how early life stress drives long-term alterations in the dopaminergic circuitry is a key first step to understanding how it contributes to PFC dysfunction which may cause asocial behavior. A better understanding of the events linking early life stress to PFC impairment will be significant as it has the potential to direct new strategies for the treatment of neurodevelopmental disorders such as ASDs.